Developmental Funds

PROJECT SUMMARY DEVELOPMENTAL FUNDS
The scientific leadership has transformed The Jackson Laboratory Cancer Center (JAXCC) in the current grant
cycle, resulting in an expanded cancer focus. New expertise in human genetics and genomics is tightly integrated
with mouse genomics expertise, supporting work to model the complexity of the human cancer genome. Integral
to this transformation was recruitment of new members through faculty hiring and engagement of existing faculty
with complementary transdisciplinary expertise. The JAXCC has expanded its capabilities in cancer genomics
and cancer systems biology, built strength in immuno-oncology and the tumor microenvironment, and
established robust translational partnerships to move basic research quickly towards clinical impact. The
membership has expanded profoundly, driven by a strengthened, cancer-focused leadership on both the Bar
Harbor and Farmington campuses, which saw the addition of 22 new members since 2013 (18 in the current
grant cycle).
Developmental funds have been crucial factors in fueling the JAXCC's growth and productivity. In the current
grant cycle, New Investigator funds were used to support nine junior faculty members, engaging them with the
Senior Leaders who mentored them as they developed their research plans. Awards are made throughout the
year with new investigators submitting a formal program plan for a two-year award. While still early for most, the
progress and productivity of these junior faculty point to the efficacy of this approach. These awards have
supported work leading to 12 publications and 14 external grants totaling $5,064,892. In the next cycle, funds
are requested for support of new investigator awards, which will be leveraged by significant institutional
commitment of funds. Plans call for adding 4 to 5 new junior-level JAXCC members in the next five years, with
a continuing emphasis on cancer genomics and immuno-oncology. Research will rely on the ongoing
development and validation of a variety of in vivo, ex vivo, and in silico systems to model cancer complexity.
The Pilot Project program is an essential part of the plan to achieve the JAXCC's strategic goals. The Senior
Leadership sets priorities and solicits pilot proposals annually through a request for applications (RFA) that
targets specific goals. Projects are awarded based on the quality of the science, their anticipated contribution to
one or more strategic goals, and the plan for securing federal funding for the mature project. In the previous
grant cycle, 17 awards have supported work leading to 14 publications and 14 grants totaling $7,619,270 (direct
costs). Funds are requested to support 2-3 new pilot projects in the first 2 years, open to all JAXCC members
and leveraging institutional match. As the membership matures, we will fund 3-5 pilot funds in years 3 to 5. Taken
together, the Developmental Funds will support the JAXCC in fostering a collaborative and dynamic cancer
program capable of advancing precision cancer medicine.